Minimizing Cancer Risk in Shift Workers

DESCRIPTION (provided by applicant): Almost 15 million Americans regularly work alternate shifts, including evening, night, and rotating shifts. Shift work is integral to the modern work force, which spans all age and ethnic groups. Observational studies have consistently associated rotating shift work with increases in cancer risk, prompting the WHO in December 2007 to classify night shift work a probable carcinogen - the main operating mechanism being assumed circadian disruption by means of melatonin suppression. Based on results from the Nurses' Health Study II (NHS2), in March 2009, Denmark as the first country worldwide began paying monetary compensation to women who developed breast cancer after 20 or more years of night shift work. Because no definitive strategy currently exists to reduce the cancer risk associated with shift work-induced circadian disruption, determining what aspects of shift schedules are most detrimental to health is the next frontier in shift work and disease prevention. To date, no study has examined how specific aspects of shift schedules including length, frequency of rotation, and hours worked per week interact and relate to cancer risk. Moreover, whether there is an age range at which people are particularly vulnerable to the effects of circadian disruption also remains unclear. Future research would benefit from a clear and complete description of work schedules and their effects on human cancer risk. In 2009, we have added a battery of shift work questions to the main NHS2 questionnaire. We newly assess specific aspects of the nurses' work schedule including types of shift schedules and changes throughout their professional career. In addition, other factors of potential relevance to circadian disruption were assessed, including morningness-eveningness and sleep duration during each of the various life time periods. To evaluate the hypothesis that certain aspects of shift work schedules are more strongly associated with breast cancer risk than others, we will use both a cohort and cross-sectional study approach. We estimate 1,108 newly diagnosed cases of breast cancer between 2009 and 2013. We will use these cases, as well as prevalent cases to enhance the power of subanalyses, for an estimated total of 4,295 women with a diagnosis of breast cancer through 2013. Because mechanisms that link shift work to breast cancer risk are similar for other cancers, the findings from this proposal are likely to affect not only the risk of breast cancer but that of other cancers and men as well. We expect that the impact of our results will extend well beyond the specific aims we currently propose. Ultimately, as time progresses and nurses become older, this data and the newly added battery of shift work questions will lay the foundation for a comprehensive and unique study of shift work on the health needs of older workers.

Public health relevance
PUBLIC HEALTH RELEVANCE: In December 2007, the WHO classified night shift work as probably inducing cancer - the main operating mechanism being assumed the suppression of melatonin and consequences thereof. Because no definitive strategy currently exists to reduce the cancer risk associated with shift work- induced changes in the body that could lead to cancer risk, determining what specific aspects of the nurses' work schedule including types of shift schedules and changes throughout their professional career are most detrimental to cancer risk is the next frontier in shift work and disease prevention. PROJECT NARRATIVE In December 2007, the WHO classified night shift work as probably inducing cancer - the main operating mechanism being assumed the suppression of melatonin and consequences thereof. Because no definitive strategy currently exists to reduce the cancer risk associated with shift work- induced changes in the body that could lead to cancer risk, determining what specific aspects of the nurses' work schedule including types of shift schedules and changes throughout their professional career are most detrimental to cancer risk is the next frontier in shift work and disease prevention. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS Almost 15 million Americans regularly work alternate shifts, including evening (4.7 M), night (3.2 M), and rotating shifts (2.5 M) or other employer-arranged irregular schedules.1 Shift work is integral to the modern work force, which spans all age and ethnic groups. While fewer women than men work alternate shifts (12.4% vs. 16.7%), there is a substantially larger proportion of female night workers in health care and social assistance professions, including nursing. Observational studies have consistently associated rotating shift work with increases in cancer risk, prompting the WHO in December 2007 to classify night shift work a carcinogen class 2A (probable carcinogen) - the main operating mechanism being assumed circadian disruption by means of melatonin suppression.2 Based on results from the Nurses' Health Study II (NHS2), in March 2009, Denmark as the first country worldwide began paying monetary compensation to women who developed breast cancer after 20 or more years of night shift work. Because no definitive strategy currently exists to reduce the cancer risk associated with shift work- induced circadian disruption, determining what aspects of shift schedules are most detrimental to health is the next frontier in shift work and disease prevention. To date, no study has examined how specific aspects of shift schedules including length, frequency of rotation, and hours worked per week interact and relate to cancer risk. Moreover, whether there is an age range at which people are particularly vulnerable to the effects of circadian disruption also remains unclear. Future research would benefit from a clear and complete description of work schedules and their effects on human cancer risk. In 2009, we have added a battery of shift work questions to the main NHS2 questionnaire. We newly assess specific aspects of the nurses' work schedule including types of shift schedules and changes throughout their professional career, including 1) their shift schedule at different ages (20-25, 26-35, 36-45, 46+); 2) number of night shifts per month; 3) type of shift work rotation; and 4) whether they work full time, part time; In addition, other factors of potential relevance to circadian disruption that have not been queried on any of the prior NHS2 questionnaires were assessed, including morningness-eveningness and sleep duration during each of the various life time periods. With these newly added questions, we propose to investigate the following set of innovative aims: 1) Shift work aims a. We will comprehensively describe the shift work profile of nurses participating in the NHS2 cohort; they comprise 70% of all registered nurses from 14 selected states within the US. b. Night and early morning shifts are associated with a higher risk of breast cancer than are day and evening shifts. c. The association between number of night shifts per month and breast cancer risk is linear. d. The association between number of years on rotating night- or early morning shifts is linear, independent of age. e. Exposure to shift work (as defined above) earlier in life is associated with a higher risk of breast cancer. f. These associations are strongest in individuals with fewer hours of average sleep and those who describe themselves as morning persons. 2) Melatonin aim a. We propose to investigate, in a subset of women in whom melatonin has already been measured (funded through CA050385), the associations between various shift work aspects and melatonin levels, to provide a biologic rational for the observations that will emerge in Aim 1. We expect melatonin levels to be lowest in women who followed the shift rotation that was most strongly related to breast cancer risk. To evaluate the hypothesis that certain aspects of shift work schedules are more strongly associated with breast cancer risk than others, we will use both a cohort (using questionnaire data) and cross- sectional study approach using urine samples (to measure 6-sulfatoxymelatonn [aMT6]) that were collected from 29,613 participants between 1997 and 1999 and stored in nitrogen freezers. We will have approximately 1,980 women with aMT6s measured through the 2013 follow-up. For the cohort approach, we estimate 1,108 newly diagnosed cases of breast cancer between 2009 and 2013. We will use these cases, as well as prevalent cases (estimated n=3,187 women alive and with prevalent breast cancer in 2009) to enhance the power of subanalyses, for an estimated total of 4,295 women with a diagnosis of breast cancer through 2013. Given the long survival after breast cancer, we do not expect to miss many women who may already have died through inclusion of these prevalent cases. However, to make sure that they did not have a different tumor histopathology, we will conduct subanalyses, evaluating differences in those parameters (i.e., hormone receptor status, histological tumor type and grade) between our prevalent and incident cases, to ensure that the inclusion of prevalent cases did not bias our estimates. Moreover, to evaluate the potential for recall bias in our prevalent cases (since information about the probably carcinogenic effect of night work has been made public through the media), we will compare the distribution of shift work aspects between women with prevalent and incident breast cancer. Further, we will conduct restricted subanalyses including only incident cases, to ensure that the addition of prevalent cases does not distort our findings. Because mechanisms that link shift work to breast cancer risk are similar for other cancers, the findings from this proposal are likely to affect not only breast cancer but other cancers and the risk in men as well. Thus, we expect that the impact of our results will extend well beyond the specific aims we currently propose. Ultimately, as time progresses and nurses' become older, this data and the newly added battery of shift work questions will lay the foundation for a comprehensive and unique study of shift work on the health needs of older workers (as supported by NIA). Specifically, we will be in a unique position to better quantify the impact of lifetime exposure to shift work on various health outcomes in addition to studying the risk of cancer, further adding to the significant overall impact of this proposal.